Intradialytic Protein Supplementation & Exercise Training in Dialysis Patients

DESCRIPTION (provided by applicant): Chronic kidney disease (CKD) patients receiving hemodialysis treatment (CKD stage 5) suffer from a variety of co-morbid diseases that may be mechanistically related. Protein malnutrition, muscle catabolism and wasting are especially common, and these lead to reduced muscle strength, declines in physical function, and low levels of physical activity. Physical inactivity exacerbates these functional declines, and also promotes cardiovascular disease (CVD) and bone disorders. This cycle of disease and disability greatly reduces the quality of life (QOL) and increases mortality rates in dialysis patients. Intradialytic protein supplementation and endurance exercise training are relatively low-cost therapies that have the potential to reduce the prevalence or severity of these co-morbid conditions, but few studies have directly assessed their efficacy. The objective of the proposed research is to evaluate the effects of intradialytic oral protein supplementation, with and without concomitant intradialytic exercise training (cycling), on measures related to physical function, QOL, CVD, and bone health. To address these questions, hemodialysis patients will be randomized to the following groups for 12 months: 1) usual care/control (CON); 2) intradialytic protein supplementation (PRO); or 3) intradialytic protein supplementation + exercise training (PRO+EX). Physical function, muscle strength, and QOL will be assessed by a variety of objective and subjective tasks, DXA will be used to measure lean mass, bone density, and abdominal aortic calcification, vascular ultrasound will be used to measure arterial stiffness and carotid intima-media thickness, and echocardiography will be used to assess cardiac structure and function. In addition, circulating levels of inflammatory mediators, mineral regulatory proteins, and growth factors that impact CVD risk and muscle and bone anabolism will be measured by standard biochemical assays to assess potential mechanisms by which protein supplementation and exercise training may influence these co-morbid conditions. We hypothesize that beneficial changes in physical function, functional CVD outcomes and risk factors, bone density, and QOL indices will occur in PRO+EX and PRO, but not in CON. Furthermore, the magnitude of these changes will be greatest in PRO+EX for all variables except those related to bone density.

Public health relevance
PUBLIC HEALTH RELEVANCE: This study will provide novel information regarding the effects of oral protein supplementation and exercise training on clinical outcomes and the QOL in dialysis patients. Results from this study will enable nephrologists to make more informed decisions regarding the extent to which these low-cost treatment strategies should be included as a component of the standard care in their clinics. Ultimately, this could lead to greater use of these treatment strategies and result in significant improvements in the health and QOL of this critically ill patient population. __SpecificAimsTextDelimiter__ A. SPECIFIC AIMS Chronic kidney disease (CKD) patients receiving hemodialysis treatment (CKD stage 5) suffer from a variety of co-morbid diseases, many of which may be mechanistically linked. Protein malnutrition, muscle catabolism and wasting are especially common, and these lead to reduced muscle strength, declines in physical function, and low levels of physical activity. Physical inactivity exacerbates these functional declines, and also promotes cardiovascular disease (CVD) and bone disorders. This cycle of disease and disability greatly reduces quality of life (QOL) and increases mortality rates in dialysis patients1, 2. Many factors contribute to the development of these co-morbidities. Chronic inflammation is believed to be a cause and a consequence of the protein malnutrition, CVD and bone disorders in dialysis patients3. In addition, abnormalities in mineral metabolism resulting from the deficit in kidney function promote the loss of mineral from bone and the deposition of mineral in the vasculature, a process termed vascular calcification (VC)4-6. VC is associated with a variety of CVD-related disorders, including arterial stiffness7, increases in arterial wall intima-media thickness (IMT), left ventricular hypertrophy (LVH), and declines in cardiac function7, 8. As a result of these abnormalities, cardiovascular events are 10 to 30 times greater in dialysis patients than in age- and sex-matched subjects in the general population9. A variety of pharmacological therapies are commonly used to help prevent or attenuate the progression of CKD co-morbidities; however, morbidity and mortality in this population remain extremely high, indicating that additional therapeutic strategies that may improve the health and QOL in this population are needed. Recently, the National Kidney Foundation recommended that dialysis patients increase their protein intake to 1.2 g/kg/day to help prevent protein malnutrition10; however, little is known about the efficacy of this recommendation. Intradialytic (during dialysis) protein supplementation has been shown to increase serum albumin levels11, and also increases amino acid uptake into skeletal muscle, an effect that is potentiated by both resistance and endurance exercise12, 13. However, the individual and combined effects of intradialytic protein supplementation and exercise training on lean mass, muscle strength, and physical function is unknown. Furthermore, intradialytic protein supplementation and exercise training improve many risk factors associated with CVD and renal bone disease (e.g., plasma lipids, inflammatory variables), but their effect on functional CVD outcomes (e.g., arterial stiffness, VC, IMT, LVH) and bone health is unknown. The primary objective of the proposed research is to evaluate the efficacy of intradialytic oral protein supplementation, with and without concomitant intradialytic endurance exercise training (cycling), on physical function, CVD risk, and bone health. We will also examine potential mechanisms for these effects, and determine if improvements in these factors lead to improvements in QOL. Hemodialysis patients will be randomized to the following groups for 12 months: 1) usual care/control (CON); 2) intradialytic protein supplementation (PRO); or 3) intradialytic protein supplementation + exercise training (PRO+EX). Primary Aim #1: Examine the effects of intradialytic oral protein supplementation and exercise training on physical function. HU ypothesis #1:U Physical function, as assessed by a shuttle walk test, will improve in PRO+EX and PRO, compared to CON, and the magnitude of improvements will be greatest in PRO+EX. In secondary analyses, we also will examine the effects of our interventions on other variables related to physical function, including lean body mass, muscle strength, and activities of daily living (ADL) assessments. Primary Aim #2: Examine the effects of intradialytic oral protein supplementation and exercise training on CVD risk. HU ypothesis #2:U CVD risk, as assessed by carotid artery stiffness, will improve in PRO+EX and PRO, compared to CON, and the magnitude of improvements will be greatest in PRO+EX. In secondary analyses, we also will examine the effects of our interventions on other factors related to CVD risk, including carotid IMT, myocardial performance, LVH, aortic calcification, and epicardial fat levels. Primary Aim #3: Examine the effects of intradialytic oral protein supplementation and exercise training on bone health as determined by bone mineral density (BMD). Hypothesis #3: BMD will be reduced U U significantly more in CON than in PRO+EX or PRO. We anticipate that BMD will remain stable in PRO+EX or PRO. Because the exercise is not bone loading (i.e., invoking ground or joint reaction forces), we do not expect additive effects of PRO+EX on BMD. Secondary Aim #1: To examine potential mechanisms by which intradialytic protein supplementation and exercise training influence CKD co-morbidities by measuring: a) circulating markers of inflammation (C- reactive protein; CRP) and oxidative stress (thiobarbituric acid reactive substances;TBARS); b) fetuin-A, a reverse acute phase protein and systemic inhibitor of VC; c) systemic growth factors affecting bone and muscle anabolism (insulin like growth factor-1; IGF-1, and IGF binding protein-3; IGFBP-3); and d) insulin sensitivity, measured by the homeostatic model assessment (HOMA) method. Hypothesis #1a: Serum CRP and TBARS will be reduced in PRO+EX and PRO, compared to CON. Hypothesis #1b: Serum fetuin-A will increase in PRO+EX and PRO, compared to CON. Hypothesis #1c: The ratio of IGF-1 to IGFBP-3, an indicator of IGF-1 availability, will increase in PRO+EX and PRO, compared to CON. Hypothesis #1d: Insulin sensitivity will improve in PRO+EX and PRO, compared to CON. Hypothesis #1e: Changes in these variables will be associated with the changes in our primary outcomes. Secondary Aim #2: Determine if intradialytic oral protein supplementation and exercise training improves quality of life (QOL) and well-being. Hypothesis #2a: Satisfaction with life and health related QOL will significantly improve in PRO+EX and PRO, compared to CON, and the magnitude of improvements will be greatest in PRO+EX.